Pharmacodynamics, Pharmacogenetics, Clinical Efficacy and Safety of Cannabidiol for Gastroparesis and Functional Dyspepsia

ABSTRACT
Gastroparesis is defined as a gastrointestinal motility disorder with objectively delayed gastric emptying in the
absence of mechanical obstruction. Gastroparesis is associated with upper gastrointestinal symptoms
including early satiety, postprandial fullness, nausea, vomiting, bloating, and upper abdominal pain. The
diagnosis of gastroparesis is based on the combination of symptoms of gastroparesis, absence of gastric outlet
obstruction or ulceration, and delay in gastric emptying (4 hour gastric emptying test). Similar symptoms may
also accompany other mechanisms of gastric dysfunction including reduced gastric accommodation and
gastric hypersensitivity. Together, these gastric motor and sensory abnormalities may cause functional
dyspepsia. Functional dyspepsia is a very common cause of substantial morbidity; it is estimated to affect 10%
of the population and manifests as abdominal pain/discomfort after eating for at least three days per week. It
has been estimated that 40% of patients with this symptom complex consult their physicians, with impact on
their workplace attendance and productivity and an economic impact in excess of $18 billion in 2009.
Development of effective treatments of these disorders is desirable, given significant unmet medical need. The
only approved drug for gastroparesis is metoclopramide, a dopamine D2 antagonist and 5-HT4 agonist; it can
be prescribed for a minority of patients for up to 3 months because of endocrine, cardiac and neurological side
effects. There is no currently approved treatment for functional dyspepsia. The non-selective cannabinoid
receptor agonist, dronabinol, was previously shown to retard gastric emptying and enhance gastric
accommodation. Δ9THC and non-pharmaceutical grade cannabidiol are used for diverse pain-related disorders;
the effects and benefit-risk ratio of these agents are unclear. With recent FDA approval of cannabidiol, our
general hypothesis is that cannabidiol relieves symptoms in patients with gastroparesis and functional
dyspepsia without deleterious effects on gastric emptying, accommodation, satiation or satiety. Our aims are:
1. To compare the pharmacodynamics and clinical effects of cannabidiol vs. placebo on satiation, fasting
gastric volume, gastric accommodation, gastric emptying, and symptoms in patients with:
1A. gastroparesis (symptoms based on Gastroparesis Cardinal Symptom Index-Daily Diary (GCSI-DD); and
1B. functional dyspepsia (+ non-delayed gastric emptying) and symptoms based on Nepean Dyspepsia Index
2. To assess pharmacogenetics effects of variants in FAAH and CNR1 genes on the pharmacodynamics
effects of cannabidiol compared to placebo on fasting and accommodation gastric volumes, gastric emptying
and satiation.
Anticipated Results and Significance: We expect these studies will lead to understanding the mechanisms
of action of cannabidiol in improving gastrointestinal functions and patient reported outcomes, including pain, in
patients with gastroparesis or functional dyspepsia, addressing unmet needs of millions of American citizens.

Public health relevance
Project Narrative / Relevance Gastroparesis and functional dyspepsia are common problems associated with many types of postprandial pain and other symptoms; they result from disorders of stomach functions including the emptying and accommodation of food. Based upon previous research, our study will test whether a newly approved pharmaceutical grade cannabidiol relieves postprandial pain without interfering with stomach functions (e.g., stomach emptying of solid food). The proposed studies provide the ability to validate use of FDA-approved cannabidiol for a non-approved indication that could address the unmet need of millions of American citizens with gastroparesis or functional dyspepsia; this research team, with its validated methods and track record, is uniquely poised to deliver on this vision.